Osseoperception, Proprioception, and Postural Control in Individuals with an Osseointegrated Prosthesis

PROJECT SUMMARY/ABSTRACT
More than two million people live with limb loss in the United States, nearly one-third of whom express
dissatisfaction regarding their socket prosthesis fit. To address socket-based issues, osseointegration is
offered as a secondary procedure with a direct connection of the prosthesis to the residual limb through a
bone-anchored implant. The direct prosthesis-to-bone connection offers a novel potential benefit to postural
control through improved osseoperception (sensation of mechanical stimulation of bones), proprioception
(knowledge of the static and dynamic body positioning), and prosthetic limb control. Up to 67% of patients with
transfemoral amputation fall at least once annually leading to diminished self-efficacy, fear of falling, and
physical activity avoidance. How individuals maintain postural control, an important objective in fall prevention,
after osseointegration remains uninvestigated. This F32 study will test a conceptual framework for the impact
of prosthesis osseointegration directly on postural control and indirectly through osseoperception and
proprioception through a two independent-groups cross-sectional design in 30 patients with unilateral
transfemoral amputation (osseointegrated-prosthesis group (n = 15) and socket-prosthesis group (n=15)). Aim
1: Osseoperception and proprioception. Osseoperception will be evaluated with a variable frequency and
amplitude vibration platform to identify sensation thresholds. Proprioception will be evaluated with standing
joint position reproduction of the knee. Aim 2: Standing and walking postural control. Standing control will
be measured using center of pressure trajectories during eyes-opened and eyes-closed standing. Walking
control will be measured by step length and width asymmetry and variability. Aim 3: Anticipatory and
reactive postural control. Anticipatory control will be measured during the anticipatory postural adjustment
phase of gait initiation. Reactive control will be measured with reaction time during standing treadmill
perturbations requiring a single recovery step. This proposal will be impactful to the clinical care of people with
transfemoral amputations because (1) prosthesis osseointegration offers a unique path to increased
osseoperception and proprioception, (2) the effects of prosthesis osseointegration on postural control are
largely unknown (3) we will comprehensively evaluate postural control, and (4) we will compare outcomes from
individuals with an OI-prosthesis to those with a socket-fit prosthesis without significant fit problems. Achieving
these aims will improve our ability to provide targeted postural control training, target decreased fall risk, and
improve health outcomes for this new and growing population of people with prosthesis bone-anchored
implants. The proposed research and training plan are impactful to Dr. Tracy’s preparation to engage in an
effective independent research career centered on the study of postural control in populations at risk for falls
by (1) learning clinical skills with a population at risk for falls, (2) developing clinical gait analysis expertise, (3)
gaining neurophysiological and advanced statistical tools, and (4) engaging in professional development.

Public health relevance
PROJECT NARRATIVE Individuals with transfemoral amputation fall significantly more often than the general population, and when fitted with a traditional prosthetic limb, nearly one-third of people experience severe complications with their prosthetic socket. Today, a secondary procedure called osseointegration is offered to address socket-related issues with a direct bone-anchored prosthesis implant, which offers a novel potential benefit to balance through improved sensation and body control. Understanding the effects of an osseointegrated prosthesis on sensation and postural control will help to identify specific functional movement deficiencies to target during therapy and rehabilitation to decrease fall risk.